Core C - Data Management and Statistical Core

REVISED PROJECT SUMMARY- DATA MANAGEMENT AND STATISTICAL CORE (CORE C) The major goals of the Data Management and Statistical Core (Core C) are to 1) enhance informatics tools and establish an integrated data management ecosystem to advance cutting-edge, reproducible research at the Wisconsin Alzheimer’s Disease Research Center (ADRC); 2) establish a system to efficiently exchange data with the National Alzheimer’s Coordinating Center (NACC) and other ADRCs as well as foster data sharing broadly with national and international researchers, in accordance with the new NIH data management and sharing plan; 3) provide comprehensive statistical support to all projects associated with the ADRC; and 4) provide outreach and educational opportunities concerning statistical methodology and data management, locally and nationally. In collaboration with the other ADRC Cores, Core C will 1) maintain a comprehensive research registry (Core E) for recruitment of participants into Center-supported studies; 2) provide a high quality, secure data management infrastructure (Cores B and G) for data collection and storage; 3) facilitate clinical research data and biospecimen sharing (Cores A, B, D, E, G) locally, nationally, and internationally; 4) develop innovative statistical methods; 5) perform data analysis and promote dissemination of research findings; 6) support active research projects, especially those involving participants from underrepresented groups and targeting health disparities research; 7) assist in the conception, design, and preparation of novel grant applications; and 8) create educational curriculum targeting data management and statistical analysis (REC). In summary, Core C plays a pivotal role in the Wisconsin ADRC’ mission to support rigorous, breakthrough research across the full continuum of Alzheimer’s disease pathobiology and train the next generation of investigators in dementia research.